The dynamic balance between neuronal volume and chloride handling in network excitability after traumatic brain injury

Project Summary/Abstract
Cerebral edema is the most significant cause of morbidity and mortality following traumatic brain injury (TBI).
Though a major target for intervention, current treatments have limited success, perhaps due to the incomplete
understanding of edema mechanisms. The task of this proposal is to dissect potential mechanisms underlying
TBI-associated neuronal edema, with a particular focus on how edema affects neuronal and network excitability
after mild and severe injury. We recently found that neuronal swelling is associated with reduced expression of
the cation chloride transporter KCC2 48 hours after controlled cortical impact (CCI) TBI. To our initial surprise,
we discovered that neuronal swelling coincided with reduced cellular and network excitability 48 hours post-
CCI. And furthermore, when we treated neuronal swelling we observed increased excitability - suggesting that
neuronal volume and excitability changes are intimately linked. These results were unexpected, as we predicted
that lower levels of KCC2 expression would increase intraneuronal chloride and reduce the efficacy of inhibition
– an effect that would increase excitability. However, the excitability of neurons is also affected by their shape:
an edematous neuron is less excitable, which may overpower effects of KCC2 on chloride homeostasis. Moreover,
despite continued reductions in KCC2 expression, neuronal volume is normalized by one-week post-CCI. This
implies that mechanisms beyond KCC2 expression are involved in neuronal volume regulation. This proposal
focuses on mechanisms of neuronal edema and its resolution after TBI. In addition, these studies will examine
the contributions of neuronal and astrocytic mechanisms on excitability following injury and during recovery.
We will test our hypotheses using genetic manipulations, simultaneous in vivo whole cell recording and two-
photon microscopy, and histological techniques. In Aim 1, we examine the mechanisms of neuronal edema at 48
hours and at 1 week after CCI and mild TBI, time points when edema is maximal and resolved, respectively. We
hypothesize that extracellular impermeant anions are the missing element in the edema response. In Aims 2 &
3, we examine how neuronal volume (and associated chloride shifts) affect excitability at 48 hours and one week
after TBI. In Aim 2, we examine to what extent: 1. GABAergic activity is rendered excitatory after TBI, and 2.
neuronal volume impacts mechanisms of chloride and water movement across neuronal membranes to influence
inhibition. In Aim 3, we assess the effects of neurons (i.e., neuronal volume and chloride transport) and
astrocytes (potassium and glutamate clearance) on excitability. In particular, we will examine susceptibility to
seizures and spreading depolarizations, which are two key consequences of the hyperexcitable network after TBI.
We hypothesize that failure to reuptake potassium and glutamate by astrocytes may contribute - in conjunction
with neuronal effects - to enhanced excitability. Our findings will result in a mechanistic understanding of
neuronal edema and excitability, including potential drug targets, which in turn could prompt a reassessment of
how and why we treat edema clinically.

Public health relevance
PROJECT NARRATIVE Cerebral edema is the deadliest consequence of traumatic brain injury (TBI), but current therapeutic interventions are only modestly successful – likely because our understanding of the basic mechanisms underlying edema remain incomplete. If successful, our results could prompt a reassessment of how we treat TBI related edema, with a focus on treating excitability as well as swelling after the event. Moreover, our studies will provide the basis for rational approaches for targeted treatments during the critical hours and days following TBI.